Project 3: Epigenomic Regulation of HTLV-1 Reactivation & Pathogenesis

PROJECT SUMMARY/ABSTRACT – Project 3: Epigenomic Regulation of HTLV-1 Reactivation &
Pathogenesis
Human T-cell leukemia virus type 1 (HTLV-1) causes adult T-cell leukemia-lymphoma (ATLL), an aggressive
lymphoproliferative malignancy refractory to therapy. Our previous work showed that chromatin insulator, CTCF,
binds HTLV-1 DNA at a single site (vCTCF-BS), and regulates virus gene expression in an integration site-
dependent manner through effects on DNA methylation and histone modifications. In addition, we showed that
a viral enhancer in the 3’ portion of the genome is important for expression of the antisense viral oncogene hbz.
The current project will define the role of epigenomic regulation by these key regulatory elements in the following
aims to determine:
AIM 1. Combined effects of vEnhancer and vCTCF-BS in HTLV-1 persistence and disease examining viral
gene expression and T-cell immortalization in culture and in rabbits and in humanized immunodeficient mice. A
multi-omic approach will examine proviral and T-cell receptor clonality in comparison to primary ATLL samples.
AIM 2. Role of chromatin insulators in HTLV-1 infection, replication, and gene expression comparing
binding sites and effects on DNA looping of CTCF, cohesin, and other interactive proteins in HTLV-1 reactivation
from latency, and in primary infected clinical samples. Effects on cohesin kockdown on virus gene expression
will also be examined. Transcriptional and post-transcriptional effects will be assessed by short and long read
RNA sequencing.
AIM 3. Impact of epigenetics on HTLV-1 pathogenesis. Effects of vCTCF-mutation will be examined in CD4+
and CD4+CD8+ lymphocytes, and in ATLL tumor samples, as well as the ability of an exogenous looping protein
to reconstitute the effects of vCTCF-BS mutation.
We expect that knowledge obtained from these studies can guide epigenomic therapeutic approaches for ATLL.

Public health relevance
PROJECT NARRATIVE – PROJECT 3 The chromatin insulator, CTCF, binds to human T-cell leukemia virus type 1 and regulates DNA methylation, looping, and histone modifications important for virus replication and development of lymphoproliferative malignancy. The current application will examine interaction of the CTCF-binding site with a viral enhancer, mechanisms underlying CTCF regulation of virus gene expression in CD4+ lymphocytes and their precursors, and the role of DNA looping in tumor progression. These data are fundamental to understanding the use of epigenomic regulatory drugs for treatment.